STUDIES OF GASTROENTERITIS VIRUSES BY ELECTRON MICROSCOPY

The electron microscope (EM) has been a mainstay for study of fastidious gastroenteritis viruses. Despite the development of 2nd and 3rd generation tests, EM remains an indispensable tool: (1) as the "surpeme court" when newer tests yield variable results; (2) in the search for new agents of viral gastroenteritis, (3) for visualizing the site of attachment of antibody to the virion in antigen-antibody reactions; (4) for serologic studies; (5) for direct visualization and fine structure characterization of the morphology of virus particles; and (6) for studying specimens derived from individuals with diseases of unknown etiology (such as non-A, non-B hepatitis) by immune electron microscopy. A new technique was introduced last year - solid phase immune electron microscopy - which was used successfully for the rapid serotyping of human and animal rotaviruses. In addition, the technique appeared to be more sensitive than conventional immune electron microscopy for rotavirus detection. This past year another new technique was introduced -- colloidal gold conjugated to protein A -- as a means of facilitating the recognition of the specific site of antigen-antibody interaction. Finally, since over 50% of the episodes of pediatric diarrhea are without known etiology, EM should continue to prove to be a valuable tool in the search for such agents.